The Dynamic Neuromodulome in Alzheimer's Disease and Aging

PROJECT SUMMARY
Neuromodulators such as dopamine, serotonin, acetylcholine, and norepinephrine play important
roles in shaping perception, cognition, and behavior. Evidence suggests that these systems may
be particularly susceptible to dysfunction in Alzheimer’s disease (AD). This dysfunction can lead
to neuropsychiatric symptoms that can appear early in disease progression, before the profound
decline in cellular integrity and associated deficits in memory and cognition that are hallmarks of
AD. These neuromodulators vary quickly from moment to moment, but it’s not clear how these
dynamics vary across aging, and when they diverge from normal aging over the progression of
AD. Understanding when these changes occur relative to well-described anatomical and
behavioral benchmarks of AD disease progression would reveal the “critical path” of
neuromodulator pathology in AD that distinguishes it from normal aging, and could suggest
potential targets for treatment or diagnosis of AD prior to the onset of memory loss and cognitive
decline. The overall goals of this project are to understand how fast activity these ascending
systems change during the progression of AD, and to enable the development of diagnostic tools
for non-invasive assessment of disease risk. We will perform systematic measurements of
neuromodulator release at multiple ages in two different Alzheimer’s disease mouse lines and
control animals using a novel combination of techniques developed by our team. We will combine
these in vivo functional measurements with anatomical data in the same mice that includes
markers of cellular pathology, axonal integrity, and transcriptomics, as well as behavioral assays,
in order to produce a multimodal atlas of disease progression bridging structure and function in
the brain’s major modulatory systems. Finally, building on our previous finding that spontaneous
fluctuations in pupil size are correlated with specific patterns of neuromodulator release in the
brain, we will attempt to build models that allow us to infer neuromodulator levels from
pupillometric measurements, and we will validate the translation relevance of these models in a
unique human data set. In summary, this project will provide the clearest view to date of
pathological changes in neuromodulator dynamics with AD, where they diverge from normal
changes during aging, and their relationship to underlying anatomical changes throughout the
brain.

Public health relevance
PROJECT NARRATIVE Individuals with Alzheimer’s disease often exhibit deficits in attention, engagement, motivation, and arousal that occur at the earliest stages of disease progression and vary substantially even across a single day; these early changes are likely indicative of changes in the neuromodulator systems of the brain. We will directly observe fast neuromodulator release in AD models and determine how it compares to normal neuromodulator function across the lifespan. These data may suggest diagnostic or therapeutic strategies that target the brain’s neuromodulator systems in the earliest stages of disease progression, before memory loss or cognitive decline occurs.